Understanding stem cell programs of regenerative neurogenesis using planarians and zebrafish

Project Abstract
Many adult organisms, including humans, turnover a significant number of neurons during life, and many non-
human organisms can regenerate substantial neural tissue following injury. New neurons in both cases are
ultimately made from adult stem cells (ASCs), yet it is largely unknown how ASCs make the correct diversity of
neural cell types at any given time while maintaining proper patterning and function in an otherwise healthy
tissue. Understanding, at the single-cell level, how ASCs can access neural fates, make appropriate numbers
and types of new cells, and then restore brain function is of fundamental importance in devising regenerative
therapies for human neural injuries. However, in order to understand the mechanisms of successful neural
regeneration, model organisms capable of both the biology and gene-function analyses must be used.
To understand complex biology of adult neural regeneration we use complementary model organisms
that can regenerate substantial parts of the nervous system following injury: the freshwater planarian and
zebrafish. Planarians have the key advantages of being able to regenerate their entire brain following
decapitation, as well as test gene function rapidly by RNAi during the regeneration process in vivo. Zebrafish
are the best genetic vertebrate model of neural regeneration and have the advantages of live-imaging and the
ability to recover from complete spinal cord transections. Only now do we have the tools in both systems to
determine the conserved mechanisms of neural regeneration at the single-stem cell level. Despite much work
from our lab and others, we understand little about stem cell heterogeneity or conserved stem cell programs of
regenerative neurogenesis in either system. This proposal addresses these unknowns. In Aim 1, we will test
four conserved transcription factors that we hypothesize drive the neural stem cell state in planarian brain
regeneration. In Aim 2, we will test 57 novel factors that we have discovered in planarians that turn on
specifically in neural-fated stem cells during brain regeneration, including two homologs of the conserved
musashi family of RNA-binding genes. In Aim 3, we will determine the first roles of the musashi-1b gene in
stem cells during spinal cord regeneration in zebrafish using conditional genetic strategies and live-clonal
analyses. Similar to planarians, musashi-1b also turns on in zebrafish neural stem cells in response to injury
and we will determine the RNA targets of musashi-1b in spinal cord regeneration. In total, this proposal will
deliver conserved mechanisms of adult neural regeneration from stem cells that will be of broad relevance to
designing regenerative therapies for human neural injuries.

Public health relevance
Project Narrative Here we use the freshwater planarian and zebrafish as complementary in vivo model systems to study central nervous system regeneration at a mechanistic, single-cell level. We propose to uncover the conserved molecular mechanisms of the neural stem cell states during nervous system regeneration in both species.